Targeted lipid-siRNA complexes for SPP1-silencing in Alzheimer's Disease

Project Summary:
Alzheimer's Disease (AD) is a fatal neurodegenera�ve disorder characterized by progressive memory loss and
execu�ve dysfunc�on. Recent research has highlighted the cri�cal role of inﬂamma�on in AD pathogenesis, with
secreted phosphoprotein 1 (SPP1) iden�ﬁed as a key driver of neuroinﬂamma�on. SPP1 levels are increased in
both the cerebrospinal ﬂuid and serum of AD pa�ents and are associated with faster cogni�ve decline. While
global SPP1 knockout in mouse models of AD has been shown to decrease amyloid plaques and reduce
neuroinﬂamma�on, the speciﬁc contribu�ons of SPP1 from diﬀerent cellular sources, par�cularly perivascular
cells, remain unclear.
The primary objec�ve of this project is to develop novel siRNA delivery pla�orms to selec�vely target and
knockdown SPP1 in perivascular cells, speciﬁcally border-associated macrophages (BAMs) and perivascular
ﬁbroblasts (PFBs), to elucidate their role in AD pathogenesis. This approach aims to address fundamental gaps
in our understanding of how the spa�al origins and temporal expression paterns of SPP1 contribute to AD
progression.
In AIM 1, I will u�lize a ﬁrst-genera�on lipid-siRNA conjugate (siRNA-L₂) to inves�gate the impact of perivascular
SPP1 on AD progression. This will involve administering siRNA-L₂ targe�ng SPP1 at early (2 months) and mid (6
month) �mepoints in the 5xFAD mouse model of AD, followed by assessment of amyloid burden and
neuroinﬂamma�on. In AIM 2, I will characterize novel siRNA-complex chemistries to op�mize cell-type speciﬁc
delivery to BAMs and PFBs. The eﬃcacy and speciﬁcity of these conjugates will be evaluated both in vitro and in
vivo.
This project leverages the speciﬁcity of siRNA technology and innova�ve delivery strategies to dissect the
temporal and cell-speciﬁc contribu�ons of SPP1 to neuroinﬂamma�on in AD. Successful comple�on of this
research will not only enhance our understanding of AD pathogenesis but also lay the groundwork for developing
targeted interven�ons that can eﬀec�vely modulate SPP1's impact on AD at the appropriate �me and loca�on.
Moreover, the cell-type speciﬁc siRNA delivery pla�orms developed in this project could have broader
applica�ons in inves�ga�ng and therapeu�cally targe�ng other key drivers of age-related neurodegenera�ve
diseases.

Public health relevance
Project Narrative Despite the substantial burden of Alzheimer’s disease (AD) as a major cause of disability and death, no effective therapeutics exist which target the neuroinflammatory hallmarks characteristic of disease pathogenesis. This proposed project will leverage and optimize cutting-edge biomolecular strategies to target the neuroinflammatory gene, SPP1, in key immune cells in the brain using short interfering RNA (siRNA). The goal of this work is to improve therapeutic outcomes in AD by reducing characteristic neuroinflammatory and amyloidogenic hallmarks of the disease.